Neural Correlates of Recovery from Aphasia After Stroke

Project Summary/Abstract
Aphasia is one of the most common and debilitating consequences of stroke. Fortunately, most individuals with
aphasia experience some degree of recovery of speech and language function over time. However, there is
great variability in terms of the extent of recovery, which has historically been poorly understood. The overall
goals of this R01 program are (1) to describe the nature of recovery from aphasia in the first year after stroke;
(2) to identify neuroimaging, behavioral, and patient-related predictors of recovery; and (3) to characterize the
neural correlates of recovery using functional and structural imaging. In previous cycles, we have recruited 380
individuals with aphasia and built an unprecedented longitudinal dataset of speech/language evaluations and
multi modal neuroimaging. We have comprehensively documented trajectories of recovery from aphasia and
their dependence on lesion location and extent, shown that this information can be used to explain much of the
variance in recovery patterns, and revealed the critical role of surviving core language regions in language
processing in people with aphasia. In the present renewal application, we propose to address several
remaining knowledge gaps and pursue opportunities for clinical translation. We will extend our ongoing
longitudinal study of aphasia recovery, recruiting 240 new individuals with acute post-stroke aphasia over the
next 4 years. We will use this expanded dataset to determine what functional changes underlie the robust
recovery that we have observed, investigating two hypotheses: (1) that reorganization may be highly specific to
individual patterns of brain damage and behavioral variables; and/or (2) that the neuroplastic changes
supporting recovery may take place primarily within surviving language regions. In Aim 1, we will identify
longitudinal changes in the functional organization of language regions associated with recovery from aphasia,
using validated semantic and phonological adaptive language mapping paradigms, and models that
incorporate information about both structural damage and behavior. In Aim 2, we will characterize longitudinal
changes within surviving language regions in terms of their representational capacity, using a new naturalistic
functional imaging paradigm and state-of-the-art language encoding models. Even as we continue to explore
the mechanisms that support recovery, we are also ready to develop tools and resources to allow clinicians to
make use of the information we have already gained. In Aim 3, we will translate our findings for real-world
clinical applications by creating a fully automated aphasia recovery prediction tool and a multimodal data
portal. Our project will inform ongoing research into behavioral and neuromodulatory interventions, and will
support clinicians in developing realistic goals for rehabilitation, optimizing allocation of treatment resources,
and providing individualized education to individuals with aphasia and their caregivers and families.

Public health relevance
Project Narrative Aphasia (acquired language impairment) is one of the most common consequences of stroke and often leads to significant long-term disability. This project seeks to better characterize the neural correlates of recovery from aphasia after stroke, and to translate our findings for clinical applications. A better understanding of the biological mechanisms that underlie recovery from aphasia will inform ongoing research into behavioral and neuromodulatory interventions, and will support clinicians in developing realistic goals for rehabilitation, optimizing allocation of treatment resources, and providing education to individuals with aphasia and their caregivers and families.